OMEGA SYSTEM MAINTENANCE, PROTOCOL DEVELOPMENT, AND OPERATOR TRAINING

The principal investigator performs periodic performance checks, routine component changes, and cryogen ordering and filling as needed for operation of the General Electric Omega 2-Tesla and 4.7-Tesla NMR systems, and assists Omega system operators as needed with protocol development and continuing training.